PHASE I STUDY OF NOVOBIOCIN IN COMBINATION WITH VP16 FOR REFRACTORY CANCER

This study has treated 26 patients. Toxicities have included myeosuppression and diarrhea. Further dose escalation and pharmacokinetic monitoring of novobiocin is planned.